Structural Mechanisms of Clostridioides difficile pathogenesis

Summary
Clostridioides difficile is a Gram-positive, spore-forming anaerobe that infects the colon, causing a range of
human disease including diarrhea, pseudomembranous colitis, and toxic megacolon. The United States Centers
for Disease Control reports that, in 2017, there were 223,900 estimated cases of C. difficile infection (CDI) in
hospitalized patients in the United States with an estimated 12,800 deaths. The incidence of community-
acquired CDI is also common making C. difficile a significant public health concern. The bacterium makes a toxin,
TcdB, which is responsible for the majority of CDI symptoms. The goal of the proposed project is to define the
structural basis and physiologic consequences of TcdB binding to receptor proteins on the host cell surface. In
Aim 1, we will define the structures and key residues involved in TcdB-receptor interactions using a combination
of structural biology, mutagenesis, and quantitative binding approaches. We will use this information to generate
C. difficile strains with defined mutations in TcdB receptor binding sites. In Aim 2, we will evaluate the cellular
tropism of the toxin in the context of a human explant intoxication model, taking advantage of significant
technological advances in high resolution light microscopy imaging. These studies will be paired with
mechanistic studies in a novel cellular model of TcdB intoxication as well as the mouse model of CDI. Collectively,
these studies will define the physiologic consequences associated with defined TcdB-receptor interactions and
are expected to provide a mechanistic framework for advancing novel therapeutic and CDI prevention strategies.

Public health relevance
Project Narrative Clostridioides difficile is a toxin-producing bacterium that is a frequent cause of hospital-acquired and antibiotic-associated diarrhea. The United States Centers for Disease Control reports that in 2017, there were 223,900 estimated cases of C. difficile infection (CDI) in hospitalized patients with an estimated 12,800 deaths in the United States. This project will define the mechanism of how the toxin engages receptor proteins on the host cell surface and thus, provide a framework for advancing novel therapeutic and CDI prevention strategies.